Can an Evidence-Based Mental Health Intervention be Implemented into Preexisting Home Visiting Programs using Implementation Facilitation?

PROJECT SUMMARY
Perinatal mental health conditions are the most common complication of pregnancy and childbirth (1 in 8 women). When left untreated, perinatal depression and anxiety adversely affects the entire family with pregnancy complications and negative outcomes including preterm birth, impaired mother-infant bonding, impaired lactation, substance abuse, divorce, suicide, and infanticide. Our previous and extensive work with multilevel stakeholders including well-established community advisory boards, underrepresented and minority women in rural geographies, and state departments of public health demonstrates the importance of social support as a mechanism for improving outcomes in perinatal depression, particularly in rural geographies. Home visiting programs (HVPs) can provide the social support needed to improve mental health outcomes in pregnant and postpartum women. Despite the known benefits of HVPs and the high rates of moderate to severe depressive symptoms among HVP recipients, home visitors report that clients with depression are more difficult to engage; a specific need exists to address perinatal mental health in HVPs. Mothers and Babies, trialed in HVPs by our co-investigator, is an evidence-based cognitive behavioral intervention that has been shown to be effective in reducing depressive symptoms, but barriers remain for maximizing adoption and fidelity within HVPs. Using an evidence-based implementation strategy that tailors implementation delivery to the needs of the specific populations and context may improve fidelity and adoption, particularly in rural states where residents have limited access to care. Our long-term goal is to improve uptake of an evidence-based maternal mental health intervention to reduce adverse maternal outcomes and improve community health. The objectives of our study are: Aim 1: Adapt implementation facilitation to support uptake of Mothers and Babies using stakeholder input; Aim 2: Analyze the effects of the adapted facilitation on implementation outcomes (i.e., adoption and fidelity) using mixed rapid ethnographic methods; and Aim 3: Determine the effect of adapted facilitation on the clinical outcomes of severity of depressive symptoms and perceived stress. We will conduct a hybrid implementation-effectiveness-context cluster randomized control trial to test the adapted facilitation strategy compared with implementation as usual (i.e., standard education). The immediate impact of this research will be to show whether adapted facilitation can improve the uptake and fidelity of a maternal mental health intervention like Mothers and Babies across multiple HVP models and thus positively affect depressive symptoms and perceived stress of recipients. Further, our implementation protocol can be used by other states to better integrate other maternal mental health interventions into HVPs, leading to further improvements in maternal mental health and further reductions in adverse outcomes for mothers, children, and families.

Public health relevance
PROJECT NARRATIVE Depression and anxiety during and after pregnancy are common medical complications contributing to a rising maternal mortality rate. Home visiting programs can offer evidence-based interventions to improve mental health outcomes for a vulnerable pregnant population; however, barriers remain to achieving the full potential of these interventions. Our work will explore the impact of context on the implementation of a mental health intervention to provide action-based and impactful data that focuses the populations served by home visiting programs across all counties in Iowa and Indiana.